RHEOLOGICAL AND ADHERENCE PROPERTIES OF SICKLE CELLS

The objective of the research is to determine the rheological and adherence properties of sickle blood cells and to establish the relative contributions of these two factors to flow disruption and stasis in the microcirculation. In order to accomplish this objective, a series of experiments are designed wth the following specific aims: 1) to determine the effects of reduced oxygen tension of the rheological properties of sickle red cells; 2) to determine if the membrane is a structural site for damage in the disease; 3) to examine the potential for micro-occlusion as caused by increased adherence of sickle red cells to vascular endothelium; 4) to examine the possible contributions of altered rheological and adherence properties of granulocytes to flow disruption, and stasis; and 5) to define the role of sickle red cell-monocyte interactions in premature red cell destruction. Direct micromechanical experiments will be used to measure the viscoelastic and plastic properties of sickle red cells as a function of oxygen tension, the rheological properties of granulocytes, the adherence of sickle red cells and granulocytes to vascular endothelial cells, and the interaction between sickle red cells and monocytes. As these red cell properties appear to depend on cell age and/or cell hemoglobin concentration, the experimental studies will be performed on density fractionated red cells with narrowly defined ranges of hemoglobin concentration. Temporal changes in sickle cell adherence properties and in the proportion of red cells with various red cell densities will be monitored in a large group of patients using newly developed methods. Detailed understanding of the biophysical and biochemical basis for the rheological and adherence properties of sickle blood cells and a study of variations in these properties in a large group of patients with varying degrees of clinical severity may enable us to define clinically important rheological and adherence properties.